Use of Ly6K specific CAR T-cells to treat primary and metastatic triple negative breast cancer

Project Summary/abstract
We have identified that increased Ly6K expression is associated with poor outcome in triple negative
breast cancer (TNBC). Mechanistically, Ly6K is required for the activation of TGFβ signaling and is increased in
tumorigenesis in vivo. We propose that the biomarker Ly6K is an ideal therapeutic target for the treatment of
TNBC because this protein is not expressed in normal cells, except in testis. Ly6K is also not required for vital
organ function, except for spermatogenesis. Thus, targeting this protein for the treatment of TNBC, a disease
affecting mostly females, is appropriate and ideal. Because of this, Ly6K is an optimal therapeutic target for
TNBC immunotherapy using CAR T-cells. CAR T-cells are genetically modified T cells which express a chimeric
antigen receptor fusion protein (CAR) derived from a monoclonal antibody (mAb) recognizing a target protein on
the surface of cancer cells. CAR T-cells can recognize and kill target cells expressing the target protein without
the need for HLA matching. We have generated three high affinity mAbs against human Ly6K, which recognize
the cell surface Ly6K on cancer cells. The sequences from Ly6K mAbs were used to generate a CAR in a third
generation lentiviral CAR vector to generate Ly6K-specific CAR T-cells. We will test whether Ly6K-specific CAR
T-cells will recognize cancer cells expressing cell surface Ly6K and eliminate them in primary and metastatic
TNBC mouse models.

Public health relevance
Project Narrative This study will determine the anti-tumor activity of Ly6K-specific CAR T-cells in primary and metastatic TNBC tumor xenograft models. This study will also determine possible side effects of using Ly6K-specific CAR T-cells. This study will use multiple models of tumor metastasis to ensure reproducibility, rigor, and will produce data required for future clinical testing of Ly6K-specific CAR T-cells.